Developmental Research Program

PROJECT SUMMARY/ ABSTRACT
The overall goals of the Route 66 Endometrial Cancer SPORE Developmental Research Program (DRP) are
to support innovative, early-stage research in endometrial cancer, to develop pilot projects to the point of
inclusion as full SPORE projects, to increase the number of investigators committed to endometrial cancer,
and to diversify the workforce. This last goal is important because less than 3% of oncologists and less than
4% of academic obstetricians and gynecologist identify as Black. Moreover, although over 80% of those
working in obstetrics and gynecology are women, fewer than 30% of tenured faculty members in Departments
of Obstetrics and Gynecology are women. To achieve these goals, the Route 66 Endometrial Cancer SPORE
DRP will provide one- to two-year pilot funding for projects in basic, translational, clinical, epidemiologic, and
cancer prevention and control research. The DRP will be open to all three participating institutions in the
SPORE (Washington University in St. Louis, University of New Mexico, and University of Oklahoma). We will
encourage investigators to submit collaborative proposals with investigators from other SPOREs. We will use
both NCI and institutional funding to support up to three DRP projects each year throughout the life of the
SPORE. Requests for applications for DRP projects in endometrial cancer research will be released once per
year. All applications will be reviewed by a Grant Review Committee consisting of scientists (representing
basic and applied science) with expertise in endometrial or related cancers or relevant science, a
biostatistician, a patient advocate, and ad hoc members, as necessary. Once a DRP project is funded, we will
provide dedicated support to ensure success of the project, evaluate progress regularly, assess outcomes, and
decide whether DRP projects should be recommended for funding as a full SPORE project in this or a future
funding cycle. As a result of the DRP, bold new ideas in endometrial cancer research will be funded at the pilot
stage and developed to lead to new treatment or prevention strategies. We fully anticipate that one or more
DRP projects will be elevated to full SPORE projects in the next funding period. Additionally, new investigators
will leverage DRP support to develop their projects, obtain preliminary data, and secure external funding and
thus establish their careers in endometrial cancer research. Finally, established investigators who are new to
the field will apply their knowledge and expertise to the field of endometrial cancer.